Signaling Mechanisms in Genome Maintenance

PROJECT SUMMARY/ABSTRACT
The stability of eukaryotic genomes relies on the tight coordination of DNA metabolic processes with DNA
repair and the cell cycle. Central to this coordination are elaborate signaling networks mediated by DNA
damage signaling kinases. Mutations in these kinases are associated with a range of human genetic disorders
linked to cancer predisposition, neurological defects, and immunodeficiency. Selective inhibitors of DNA
damage signaling kinases are now being used in over a hundred clinical trials for cancer therapy. However,
fundamental questions related to how these kinases maintain genome integrity remain unanswered. The
Smolka Laboratory investigates DNA damage signaling, with a major focus on the phosphatidylinositol 3′
kinase (PI3K)‐related kinases (PIKKs) and PIKK‐regulated downstream checkpoint kinases. In addition to
pioneering the use of proteomic approaches for the unbiased mapping PIKK substrates, our work uncovered
new mechanisms of DNA repair regulation and DNA damage signaling deactivation. Over the next five years,
our research program will explore novel non-canonical roles for PIKKs in genome maintenance and DNA
replication that have remained obscured for decades. We will address fundamental questions regarding the
identity of key effector proteins by which PIKKs control DNA synthesis and DNA repair transactions,
establishing the underlying mechanisms of phospho-regulation and implications for manipulating cellular
viability, fitness and drug susceptibilities. We will employ extensive phosphoproteomics and genetic
approaches, and incorporate single molecule super resolution microscopy, CRISPR screens and genomic
technologies. The proposed work will reveal crucial, yet undefined, layers of PIKK-dependent regulation
governing genome maintenance and DNA replication in yeast and mammals. Generated knowledge will also
have implications for understanding how cells with unstable genomes, such as cancer cells undergoing
oncogene-induced replication stress, co-opt PIKK signaling for unrestrained proliferation and resistance to
genotoxic insults. Moreover, our findings will illuminate how inhibitors of PIKKs, already in clinical trials,
affect cell viability and genomic integrity, thus informing the design of more effective therapeutic strategies.

Public health relevance
PROJECT NARRATIVE Damage to our genetic material is a threat to our survival and a driving force of many diseases. This proposal investigates how cells protect the stability of the genome. The generated knowledge will have direct implications to understand tumorigenesis and will help in the design of more effective anti-cancer therapies.